Investigating how RNA modifications regulate adaptive mRNA translation.

The recent strides of epitranscriptome mapping have unveiled the complex landscape of RNA
modifications and their essential role in gene expression regulation. Modifications of transfer
RNAs (tRNAs) are critical for proper folding, stability, and decoding function, all essential for
enabling precise and efficient translation. Dysregulation in tRNA modification pathways and their
associated catalytic enzymes has been implicated in the disruption of mRNA translation
processes, contributing to the pathogenesis of numerous human diseases. Emerging evidence
demonstrates that tRNA modifications are dynamic and can be regulated in response to cellular
stress, indicating that they are likely essential to the orchestration of translational programs that
maintain cellular homeostasis, thereby preventing disease development. Our overarching goal is
to understand how the regulation of human tRNA modifications influences mRNA translation
dynamics and their importance in maintaining normal cellular physiology. This proposal is focused
on elucidating the roles of TRMT1L, a newly characterized m22G tRNA methyltransferase, which
we have shown is essential for the deposition of other modification important for tRNA function
and cellular stress response. We uncovered that TRMT1L interacts with the RIX1 ribosome
biogenesis complex, indicating a previously unexplored connection with ribosome biogenesis
machinery and tRNA modification regulation. The underlying hypothesis of our research is that
the RIX1 complex interacts with TRMT1L to regulate a tRNA modification circuit essential for
establishing an mRNA translational program in response to stress. In Aim 1, we will test whether
the RIX1 complex is essential for TRMT1L-mediated tRNA modifications using a combination of
ChIP, molecular interaction assays and tRNA modification analysis. In Aim 2, using a combination
of RNA methyltransferase assays, mass spectrometry analysis, and direct tRNA sequencing on
the Oxford Nanopore platform, we will test the role of TRMT1L in regulating a new tRNA D-loop
modification circuit. We will also assess whether these downstream modifications change in
response to stress and how they affect tRNA function. Finally, using an unbiased Ribo-seq
approach to profile actively translated mRNA at high resolution, we will investigate changes in the
translational landscape regulated by TRMT1L in cells recovering from the oxidative and
endoplasmic reticulum (ER) stresses (Aim 3).

Public health relevance
A growing body of evidence indicates that tRNA modifications have a profound influence on the regulation of translational programs in response to cellular and environmental changes. We aim to elucidate how endoplasmic reticulum and oxidative stress regulate tRNA modifications and determine how this contributes to the establishment of an adaptive mRNA translation program for stress survival.